Prevention and Treatment of Cardiovascular Disease in Patients with Chronic Kidney Disease: Patient-Oriented Research and Mentoring

PROJECT SUMMARY
Over 10% of the world’s population has chronic kidney disease (CKD), and cardiovascular disease is a primary
cause of morbidity and mortality. Approximately 50% of patients with advanced CKD die from cardiovascular
disease. However, there is limited evidence to inform optimal strategies for prevention and treatment of
cardiovascular disease in this population. The pathology of cardiovascular disease may differ in the presence
of CKD compared to the general population, and cardiovascular therapy may have distinct risks and benefits.
Guidelines on the use of medications to prevent or treat cardiovascular disease in persons with CKD are often
unclear or conflicting. The overarching goal of this K24 application is to address major gaps in the evidence
surrounding cardiovascular disease development, prevention, and treatment in patients with CKD, providing
junior investigators with the rigorous training and mentorship needed in order to advance the field. The
candidate, Dr. Morgan Grams, MD PhD, is a nephrologist and epidemiologist with expertise in clinical research
methods and a strong track record of successful mentorship. Dr. Grams’s research portfolio provides ample
data and opportunity to address clinically important questions at the intersection of cardiovascular disease and
CKD, including the molecular basis of cardiovascular prognosis in CKD as well as the safety and effectiveness
of approved cardiovascular therapy across the range of kidney function. The K24 will allow Dr. Grams to
expand her mentoring to ensure the next generation of patient-oriented researchers are able to take advantage
of the ever-growing availability of health care data to complement and enhance pre-clinical work and clinical
trials.

Public health relevance
NARRATIVE The goal of this Mid-Career Investigator Award in Patient Oriented Research is to provide support for mentoring and research in the study of cardiovascular disease and chronic kidney disease. Dr. Morgan Grams is a nephrologist and epidemiologist with broad expertise in applying quantitative clinical research methods to large data sources and a strong track record of successful mentorship. The K24 will allow Dr. Grams to expand her mentoring to ensure the next generation of patient-oriented researchers are able to take advantage of the ever-growing availability of health care data to answer clinically important questions in the field.